Role of epithelial barrier function in food-induced anaphylaxis

Role of epithelial barrier function in food-induced anaphylaxis
ABSTRACT
Food allergy is a growing public health problem with approximately 15 million people affected in
the United States. In allergic food disease, IgE on mast cells bind to ingested antigens leading to
the activation and degranulation of mast cells. In order to activate mast cells, food antigens must
pass through the intestinal epithelial barrier and activate cells in the lamina propria. Junction
Adhesion Molecule-A (JAM-A) is a tight junction transmembrane protein that plays a major role in
the maintenance of barrier function in epithelia and endothelia. In the small intestine, JAM-A has
been shown to be important in epithelial barrier function, and mice that lack JAM-A (JAM-A-/-)
have increased intestinal permeability. These JAM-A-/- mice develop severe food allergic disease
compared to WT animals and have increased mast cells in the lamina propria of the small
intestine, as well as increased activation of these cells. In this proposal, we aim to better
understand the role of JAM-A in the development of severe food allergy, including the induction
of a strong Th2 response that results in mast cell accumulation in the small intestine. We further
plan to target those mast cells in susceptible animals with the aim of decreasing the allergic
response. To do this, we will neutralize stem cell factor (SCF), a cytokine that is required for the
growth and activation of peripheral tissue mast cells. We hypothesize that neutralizing SCF will
prevent mast cell accumulation and protect from severe anaphylactic reactions. These
experiments will contribute to our understanding of barrier function in food allergic reactions, as
well as provide a potential method for decreasing these reactions in the presence of a
dysregulated barrier.

Public health relevance
Project Narrative The small intestine is separated into two main parts, the lumen where food passes through, and the lamina propria, where immune cells reside. A single layer of cells separates these two parts and provides a selective barrier that prevents bacteria and food particles from passing though, while allowing nutrients to leave the lumen. This proposal investigates how a breakdown of that barrier may lead to severe reactions in food allergy, whereby food proteins inappropriately move from the lumen and activate immune cells in the lamina propria, leading to anaphylaxis.